CT imaging-based prediction and stratification of motor and cognitive behavior after stroke for targeted game-based robot therapy: Diversity Supplement

Project Summary
With stroke being the leading cause of disability worldwide, there is a need to improve current rehabilitative care.
Furthermore, the burden of care is significant, and many developing countries do not have the resources
necessary to treat people with stroke. With a focus on affordability, the parent project aims to develop and
integrate a haptic robot into a community-based environment to treat patients with residual cognitive and motor
impairments due to stroke. These 1 degree-of-freedom haptic robots apply torques via novel end-effector
assemblies that can support and facilitate reaching and grasping motor recovery in the upper limb. The parent
grant aims to plans to leverage single and grouped haptic robots and serious gaming to dynamically adjust and
personalize therapy for patients presenting along motor and cognitive impairment spectrums. There are four
proposed treatment groups based on patient functional behavior: low cognitive/low motor, moderate
cognitive/low motor, low cognitive/moderate motor, and moderate cognitive and moderate motor. The parent
grant focuses primarily on quantifying changes in patient functional behavior without connecting these changes
to neural substrates that may underpin motor and cognition.
This diversity supplement will focus on training a talented pre-doctoral student to develop novel
algorithms that can support the community-based application of the robot systems. In the community-based
rehabilitation setting and nursing homes, there is often limited chances to use brain imaging to help target
treatment. Imaging platforms are typically expensive and therefore clinicians rely on only functional behavior to
determine treatment direction. A computed tomography (CT or CAT) scan allows doctors to see inside the brain
and is often an extremely affordable imaging method that can provide insight into the brain state after stroke.
The goal is to leverage this technology to create predictive algorithms that can support personalization of our
robot-assisted treatment based on the potential impact of lesion parameters on motor and cognitive function.

Public health relevance
NARRATIVE Implementing affordable design is a fundamental strategy for increasing access to rehabilitation technology for stroke patients. In this diversity supplement, we propose using the combination of affordable imaging with affordable rehabilitation technology to augment robot-assisted neurorehabilitation for stroke patients. The success of this proposed effort may allow the parent grant to offer more personalized care, which will decrease healthcare disparities and long-term healthcare costs for the stroke survivor.